Research Training Program in Behavioral and Biomedical Sciences

PROJECT SUMMARY/ABSTRACT
The Research Training Program in Behavioral and Biomedical Sciences (BBS) at West Virginia University is
designed to provide advanced research training at the interface of behavioral and biomedical sciences to PhD
students planning careers as independent investigators. The BBS Program draws on existing, high-level training
in the Biomedical, Psychology, and Public Health PhD Programs and provides considerable added value
through curricular offerings (including behavioral neuroscience methods, biostatistics, bioinformatics, and
epidemiology), a highly interactive journal club and an extensive seminar series. Specific training and
experiential activities also are provided to foster scientific leadership, communication skills, teaching excellence,
responsible conduct of research, and cognizance of issues related to human health, physiology, and disease.
Structuring the BBS Program to leverage the strengths of the Biomedical, Psychology, and Public Health PhD
Programs ensures an experienced and productive preceptor group, a wide range of research training
opportunities, and a highly qualified and diverse applicant pool. The BBS Program remains committed to
successful recruiting of underrepresented minority, disabled, and disadvantaged students; programs and
partnerships have been developed to address this issue. The BBS Program provides a proven vehicle for
training the next generation of scientists with the intellect, knowledge, experience and courage to address
complex research problems with significant

Public health relevance
PROJECT NARRATIVE The Research Training Program in Behavioral and Biomedical Sciences (BBS) at West Virginia University prepares scientists for successful careers in biomedical research. Trainees learn transferable skills needed to address significant public health issues related to behavior or behavioral risk factors. Training focus areas include neuropsychiatric and neurological illnesses, cardiovascular disease, and substance abuse, all of which are areas of notable health disparities in West Virginia and Appalachia.